Genomics, Biometrics and Identity

Project Summary/Abstract Section As concerns for national security increase, policymakers are turning to genomics as a biometric for tracing individuals entering the country, identifying missing persons’ remains, processing refugee claims, and screening for human trafficking. Increasingly, genomic information is a part of legislation and policy as a universal and sustainable biometric. Genetic verification of claimed relationships is required for some refugees and proposed legislation would expand this practice. Efforts to thwart fraud and human trafficking include use of DNA relationship testing to verify claims. In addition, courts are considering DNA testing for ancestral origin to verify refugees’ ethnicity claims, which may help stateless persons and refugees seeking asylum that lack citizenship documentation and travel papers. The U.S. has had the authority to collect DNA of federal detainees for the criminal database since 2009, and with mass disasters and terrorism a real concern, establishing broad public DNA databases could benefit disaster victim identification efforts and terrorism investigations, but also lead to stigmatization and push boundaries of human rights and Constitutional protections. The use of biometrics in the U.S. could have profound implications on families both within the U.S. and in non-U.S. countries of origin. Given the international attention to the current population crises, policies in the U.S. are expected to expand over the next few years. This is likely to include the implementation of genomics for verification of claimed relatives, as is already policy in pre-existing visa programs, and increased use of rapid DNA instruments. The social implications of these technologies applied in practice, particularly in populations that could be considered vulnerable, are understudied and the potential impact of genomics as a biometric is undocumented. In this proposal we will examine existing and emerging U.S. laws and policies that incorporate genomics. This project can inform development of emerging policies to minimize intrusiveness and mitigate the social implications of non-medical decisions based on biological data. We will develop case studies and policy briefs to document the status of current policies using genomics and examine the oversight and reporting mechanisms in non-medical DNA testing (Aim 1). We also will interview and engage with stakeholders and authorities involved in genomic testing for select cases to outline the potential risks and benefits both for individuals and national interests (Aim 2). Achieving these aims will bring clarity to the scope of how genomics is integrated into policy, how new tools may be implemented in the near future, and what approaches may be considered to protect the privacy of persons while maintaining the integrity of the processes for the best interests of the nation and national security. The anticipated contribution of this research project will be data and policy analyses that facilitate policy development and program implementation in ways that promote the equality and dignity of all humans.

Public health relevance
Public Health Relevance Section Policies in the U.S. increasingly rely upon genomic information as a biometric to inform visa application processes, by verifying biological relationship claims or statehood claims, and broad DNA collection from non-criminals may help with missing persons, disaster victim, and terrorism investigations. The societal implications of these genomic applications are broad, with benefits and risks to the individuals undergoing testing, the communities in which they live, and the nation at large. This study will highlight the benefits and challenges of incorporating genomic information into policies, examining (1) how genomics is integrated into border processes, (2) the implications of new genomic tools to be implemented in the near future, and (3) perspectives on approaches to protect autonomy and privacy interests of individuals while maintaining the integrity of the genomic data and processes essential for national security.